Functional characterization of understudied protein kinases implicated in developmental disorders using zebrafish

Summary About 3000 protein-coding genes in the human genome encode druggable proteins that can bind to small molecules. Most of these “druggable genes” encode proteins that belong to just three protein families: protein kinases, non-olfactory G-protein-coupled receptors (GPCRs), and ion channels. Drug discovery projects have focused on well-studied proteins from these families. As a consequence, FDA-approved drugs target only a fraction of these ~3000 druggable genes. There is an urgent need to fill this gap and inform novel therapeutic strategies for human disease. To meet this need, the NIH’s Illuminating Druggable Genome (IDG) program has prioritized a list of over 300 understudied protein kinases, GPCRs, and ion channels. High throughput screens in diverse cell types and model organisms are a mainstay of drug discovery. Zebrafish are amenable to high throughput screening and, as vertebrates, can closely recapitulate the complexity of human development, homeostasis, and disease. These advantages make zebrafish uniquely well suited to uncover clinically relevant drugs. We and others have optimized the CRISPR/Cas9 mediated mutagenesis method to screen for phenotypes in the F0 generation by generating biallelic mutations. This breakthrough accelerated our ability to uncover the functional consequences of hundreds of mutants from months to days. Mutations in kinases can lead to diverse dysfunctions in humans, including cancer, aberrant development, and metabolic disorders. We analyzed 150 of the understudied kinase genes listed in RFA-RM-20-109 and identified 126 zebrafish orthologs. Of these 126 genes, mutations in 21 are known to cause developmental disorders in humans. The objective of this proposal is to establish zebrafish models for these 21 understudied genes that encode druggable kinases. We will achieve our objective and test our hypothesis via the following aims: 1) Generate a Library of Zebrafish Mutants Corresponding to 21 Candidate Developmental Disorder Genes. 2) Elucidate the functional consequences of gene knockouts during embryonic development. We expect that 8-10 of the 21 druggable genes will have early development phenotypes in zebrafish and generate disease models for further functional studies. Our library will be useful not only for studying disease pathology but also for functional testing of kinase inhibitors to elucidate their targets. Our mutant collection will facilitate drug screening to identify new therapeutics for many human diseases and will be widely available through the Zebrafish International Resource Center (ZIRC).

Public health relevance
Project Narrative A large number of genes in the human genome are understudied, many of these genes are druggable and can bind to small molecules. Currently, a fraction of these genes can be targeted by FDA approved drugs because of a lack of knowledge on these understudied genes. We will generate zebrafish models to understand the function of 21 understudied kinase genes implicated in developmental disorders; these models will allow researchers to identify new drug targets and understand their roles in disease pathology.